Developing a Data-Driven Management System Using Machine Learning and Mixed-Methods Research to Predict Job Turnover Among MentalHealth Professionals

March 11, 2021 Michael C. Freed, Ph.D. Chief, Services Research and Clinical Epidemiology Branch Division of Services and Intervention Research National Institute of Mental Health / NIH Office: 301.443.3747 Email: [email] RE: Statement of Candidate Eligibility for a Diversity Supplement to R34 MH119411 (PI: Sadaaki Fukui, Indiana University) Dear Dr. Freed, I am submitting a request for an NIH Diversity Supplement to my parent grant R34. This supplemental request is to support Dr. Eric Kyere who is an assistant professor at Indiana University (IU) School of Social Work. Dr. Kyere is eligible for a diversity supplement as a permanent resident who is originally from Ghana. He is a highly motivated scholar aiming to advance racial equity and justice, making him an ideal candidate for this supplement. Dr. Kyere, who is also a racial minority in the United States, is very passionate about understanding the mechanisms and factors of structural racism and identifying methods to tackle the issue. In order for him to continue his research efforts, he has been preparing for tenure at IU. This diversity supplement is an excellent opportunity to help Dr. Kyere reach his career goals as we describe in the attached proposal. Our supplement research goal (i.e., addressing the racial disparities in the mental health workforce) strongly aligns with the current NIMH strategic plans for strengthening the academic and mental health workforce by recruiting and retaining people from diverse backgrounds. Ensuring the success of diverse academic faculty is critical not only for the minority faculty member but also for us to recruit more diverse students and trainees who eventually will diversify our mental health workforce. Our effort ultimately could improve service access and quality for our minority clients. The supplement will help facilitate Dr. Kyere’s career development as he applies his knowledge and skills to a new project under Aims 2 and 3 of the parent R34 and develops preliminary data that will help him be more competitive for external funding. He will apply for tenure and promotion at IU during the 2022-2023 academic year, and the timing of this award will be ideal. To support his career goals through this diversity supplement, we have created supportive environments to provide quality mentoring. We appreciate your consideration of this proposal. Please let me know if you need additional information. Sincerely, Sadaaki Fukui, PhD., MSW., MA Steven Allen Martin Associate Professor Associate Vice President for Research Administration Indiana University Indiana University School of Social Work

Public health relevance
Candidate Statement Eric Kyere, Ph.D. Introduction I am excited to apply for an NIH Diversity Supplement through Dr. Fukui’s R34 grant: Developing a data-driven management system using machine learning and mixed-methods research to predict job turnover among mental health professionals. Under the mentorship of Dr. Fukui, the Diversity Supplement will enable me: (1) develop an in-depth understanding of the experiences of Black employees who provide direct mental health services, and particularly, how they conceptualize their experiences in relation to their decision to stay or leave their organization; (2) increase my statistical knowledge and skills in sub-population data analysis; and (3) strengthen my research portfolio by establishing my expertise in addressing the potential racial disparities in the mental health workforce among persons of African descent. My ultimate goal is to promote a just, fair, and equitable world. The successful completion of work undertaken through Dr. Fukui and his team’s mentorship will improve my ability to secure tenure and sustain my research efforts for addressing structural racism against mental health workers of African descent. Structural racism in the workplace may also affect the health and well-being of their client systems and ultimately society at large. The Diversity Supplement is a great opportunity for me to achieve my research and professional development goals. I am an Assistant Professor at the Indiana University School of Social Work and an Adjunct Professor in the Africana Studies Department at Indiana University. As an immigrant of African descent, originally from Ghana, my research focuses on racism and race (grounded in the racial disparity’s framework), examining the various ways that structural racism may impact the psychosocial, health, and overall well-being of persons of African descent or Blacks, and developing innovative solutions. My professional experiences within mental health organizations, as well as ongoing community engaging research within Black communities, have shown me that the workforce (especially in mental health organizations) has a critical impact on how structural racism affects the psychosocial, health, economic, and overall well being of Blacks within the organization. Such racial disparities in the mental health workforce in turn may create gaps in mental health organizations’ abilities to serve increasing-diverse client systems. African Americans have been engaged in a series of struggles against cascading racial oppressive forces (including slavery, domestic terrorism, Jim Crow segregation, intentional economic subordination, and racialized mass incarceration) over the course of centuries. Research Gaps As I continue to develop my research agenda with a strong focus on structural racism, I recognize African Americans have made significant strides in several domains of life; however, very visible and vexing racial inequalities (in psychosocial, economics, and health outcomes) persist within the mental health domain and impact performance and retention of Black and other workers of color. Moreover, while structural racism has been suggested as the fundamental driver of racial disparities in the job retention rate and health of Black workers, research has still understudied and undertheorized the impact of structural racism, especially in mental health organizations. Additionally, research, which has examined interpersonal racial discriminations against Blacks in the workplace, is limited when providing rich contextualized experiences that highlight the nuanced realities of racialized experiences of Blacks who work within mental health organizations. From an evolutionary standpoint, structural racism and how it operates are dynamic and respond to the vicissitudes of time. However, there are gaps in the research, since current approaches to measuring and analyzing racism continue to rely on more overt forms of racism. This way of investigating racism limits our ability to accurately measure racism, especially structural racism in the post-Civil Rights era, which in turn constrains our ability to generate relevant knowledge to inform solution-based decisions that address racism within organizations. This Diversity Supplemental grant, under the supervision of Dr. Fukui and his team, will provide me with the opportunity to apply qualitative methodologies to an in-depth investigation of the impact of structural racism with which Black employees (who provide mental health services in mental health organizations) have to contend. We anticipate that the findings will inform policy and practice intervention to enhance organizational culture and conditions for Black and other employees of color to improved job retention and work performance. Under Dr. Fukui’s mentorship, I will work with the research team on the R34 grant, which includes graduate research assistants, to develop qualitative interview protocols and conduct interviews and analysis to identify ways racism operates through organizational processes to affect Black employees’ decisions about their job retention and turnover. I also will analyze the administrative and survey data that have been or will be collected in the parent R34 in order to understand the potential racial disparities that disproportionately affect Black employees. We have planned several sub-population analyses to address our research hypotheses. Research Interests to Address the Gaps As a junior researcher on a tenure track position at the Indiana University School of Social Work, it is important for me to strengthen my research focus on structural racism and its impact on Blacks. It is also important to secure external grants to generate research knowledge that offers innovative solutions to structural racism toward persons of color and in society at large. As part of achieving this goal, I will use the data that will be gathered from the qualitative and quantitative inquiries from Dr. Fukui’s R34 in order to apply for an NIMH grant to work with Dr. Fukui and the research team. Our planned proposal will address structural racism that may impede inclusive and diverse work environments and undermine people of color’s productivity and job retention within mental health organizations. I just completed training on Group Concept Mapping (GCM): a community-based participatory research that uses social dialogue to engage with research participants to generate insights on community concerns and potential solutions (e.g., anti-racist framework), identify implementation strategies, and develop evaluation plans that represent the voices of the stakeholders affected by the problem (in our study, Black employees within mental health organizations). I am planning to use GCM as a core methodology for our planning grant. Securing external grants will enhance my prospect for tenure at my school and position me to advance research on racism and race to serve the Black community and promote racial justice. Our planning studies could contribute to building a diverse and resilient workforce and ultimately the vitality of a racially diverse society, which is strongly aligned with the NIMH strategic plans. My Educational and Training Background My PhD education has provided me with strong methodological and analytical frameworks (e.g., quantitative, qualitative methods, critical institutional analysis) from transdisciplinary perspectives to engage with organizations and individuals in order to understand the nuanced ways by which structural racisms (through institutional or organizational cultures) may affect persons of African descent. They include the various coping and resistance strategies Blacks initiate to resist or cope with their racialized experiences. My research approaches have been focused to identify and interrupt the mechanisms by which racism revives itself through institutions/organizations and fostering a working culture that is responsive to persons of African descent in order for them to thrive, thereby increasing their effectiveness and productivity. However, since my doctoral graduation and joining the faculty at the Indiana University School of Social Work, my work has mostly focused on quantitative secondary data analyses using publicly available data and conceptual methodologies. Further, I have not had the opportunity to collect original data or conduct research within externally-funded projects. Acquiring the procedures and conducts of externally funded research is critical for me to grow as a researcher and to become a future research mentor in this field. Importance of Mentorship I am, therefore, highly motivated and excited to submit this Diversity Supplement grant. The proposed training fellowship, under the mentorship of Dr. Fukui and his team, will provide me with the opportunity to work with the research team on the parent R34 grant to apply my knowledge and skills to understand the experiences of Black employees regarding turnover and retention and to use the data in order to inform the creation of an inclusive work culture that is grounded in the racial disparity framework (e.g., understanding the vast differences, which are unrelated to individual and biological traits, that exist in the experiences, psychosocial, health, and performance of persons of color compared to Whites). Race conscious (rather than colorblind) policies and practices are critical to identify, validate, and address these differences. Dr. Fukui is one of the senior colleagues who is committed to the development and retention of junior faculty at the Indiana University School of Social Work. He has provided me with critical feedback on research, manuscripts, and grant writings. I have worked with him on several manuscripts and grant applications. One of our manuscripts that investigated the impact of racial discrimination on African American youth’s depressive symptoms was recently published. While my work has not been directly on Black employees’ turnover within mental health organizations, my related experiences working in the mental health field as well as my ongoing research and engagement with persons of African descent situate me to make significant contributions to addressing racism within mental health organizations, including the significant issue of turnover among employees of color. Most importantly, the Diversity Supplement grant will provide me with secured training time and solid research experiences with Dr. Fukui, given his long-standing research and experience with mental health organizations, his willingness to mentor me, and my passion and motivation to contribute to addressing structural racism. I am excited about this opportunity and look forward to a favorable decision on this application for my professional development and growth. Summary The Diversity Supplement will secure the quality mentoring time and experiences with Dr. Fukui and his team that will be critical for me to develop my expertise in addressing racial disparities in the mental health workforce. The training also will facilitate my capacity for acquiring external funding and securing my tenure at IU.